Mechanisms of glial detection of axonal injury and facilitation of axonal regeneration

PROJECT SUMMARY
300,000 Americans suffer paralysis from spinal cord axon injury. Glia permit axon regeneration by
clearing debris, partly through autophagy. Inappropriate release of glial debris can inhibit axon regeneration. To
treat axon injuries, it is essential to understand mechanisms of glial recovery after axon injury, permitting glia to
facilitate axon regeneration. Larval fly sensory neurons are a genetically-tractable model for axon regeneration
in the mammalian peripheral nervous system, with regrowth dependent on wrapping glia. In my postdoctoral
experiments, I have discovered that fly sensory glia release large exopher-like vesicles (ELVs) (~3 µm) at the
injury site, a phenomenon previously undescribed in glia. Glia also display membrane damage and subsequent
repair at the injury site, and loss of wound healing pathway components results in diminished axon regeneration.
These data suggest that glia may adapt to the stress of axon injury through ELV release and membrane repair.
Exophers, large (~3 µm) vesicles so far documented in C. elegans neurons and mouse cardiomyocytes,
sequester oxidatively-stressed mitochondria for release. In mice, the autophagic pathway is required to produce
exophers. My preliminary experiments in fly larvae showed loss of an essential autophagy regulator results in
smaller glial ELVs and reduced axon regeneration. Together, these data suggest that the wound healing and
autophagic pathways are important for glial ELV production and axon regeneration. As previous work in exophers
revealed modes of stress recovery, understanding the origins of fly glial ELVs could uncover novel mechanisms
of glial recovery from the stress of axotomy, likely necessary for glia to facilitate axon regeneration. This
proposal aims to define the origins of this novel glial ELV response and its effects on axon regeneration.
Aim1 of this proposal will identify the cell responsible for autophagy-mediated glial ELV release and axon
regeneration by utilizing glial- and neuronal-specific RNAi knock-downs. Furthermore, Aim1 will use electron
microscopy and fluorescent reporters to determine if ELVs isolate stressed mitochondria, akin to exophers, in an
autophagy-dependent manner. Aim 2 of this proposal will identify the cell-responsible for wound-healing
mediated axon regeneration, interactions between wound-healing and autophagic pathways, and effects of the
wound-healing pathway and extrinsic signals on glial ELV release. This will be achieved via glial- and neuronal-
specific RNAi knock-down constructs for components of the wound healing pathway, antibody staining for wound
healing components, and a genetic system to simulate axotomy without physical injury. This proposal will uncover
novel mechanisms of glial recovery and glial facilitation of axon regeneration. These studies may help inform
and improve methods to drive human axon regeneration in the CNS and PNS, aligning with the mission of
NINDS. With the expertise of the Song lab and my postdoctoral advisory team, I will gain a comprehensive
understanding of the relevant cell biology fields and necessary technical skills, uniquely positioning me to tackle
my scientific proposal. I will expand these projects in my own research group as an independent investigator.

Public health relevance
PROJECT NARRATIVE Injury to axons in the central and peripheral nervous systems can have devastating consequences, often resulting in paralysis due to limited axon regeneration. Glia are critical for promoting axon regeneration – creating a permissive environment by clearing axonal and glial debris or inhibiting regeneration by releasing debris into the environment – but the mechanisms of glial adaptation to the stress of axon injury are unclear. In this proposal, I will identify the molecular and cellular basis of a novel glial recovery response to axon injury and its necessity in promotion of subsequent axon regeneration.